Administrative Core

Project Summary
The Administrative Core is led by Drs. Panagiotis Konstantinopoulos, Joyce Liu, and Ursula Matulonis who are
in addition the Principal Investigators (PI)/Program Directors (PD’s) of this resubmitted P01 grant. The
Administrative Core will provide organizational leadership and administrative management of this P01 grant,
monitor the progress of Projects, and coordinate the internal and external communication amongst the Projects
and Cores within the P01 grant.
The structure of this P01 grant will allow close supervision and monitoring oversight of all Projects and Cores
equally by Drs. Konstantinopoulos, Liu, and Matulonis. The Administrative Core Leaders will monitor projects
through regularly scheduled meetings with all of the Project and Core leaders, teams, and key investigators
and will interface with a very accomplished External Advisory Board (EAB), Internal Advisory Board (IAB) and
advocates. The EAB and IAB will review the progress made on the specific aims, accrual to clinical trials if
applicable, results of specific experiments outlined in the grant, abstracts and publications as well as pitfalls or
roadblocks that have occurred. The Administrative Core leaders will also be responsible and accountable for
the proper conduct of the project or program including the submission of all required reports and will also share
fiscal and resource oversight of this grant.
The Administrative Core will also be responsible for integration and collaboration within this Endometrial
Cancer P01 grant and to ensure seamless and effective communication within this P01 grant as well as
external dissemination of the results. The Administrative Core will also integrate the Projects and other Cores
across DFCI, the Brigham and Women’s Hospital, as well as the Dana-Farber/Harvard Cancer Center.
Communication of results within the P01 grant team and externally will be facilitated by this Administrative
Core and will be the responsibility of this Core. Drs. Konstantinopoulos, Liu and Matulonis will assist
investigators in this endometrial cancer P01 grant to publicly disclosed results at academic meetings.

Public health relevance
Project Narrative The Administrative Core of this P01 Program will help meet the public health goals of the NCI by studying replication stress in uterine cancer and devising new therapeutic strategies for women with uterine cancer. Uterine cancer incidence is rising in the United States, survival is decreasing, there is a rise in the incidence of non-endometrioid cancers, and additionally, survival of black women with endometrial cancer is significantly worse than non-black women (www.seer.gov). The goals of this P01 application are to improve outcomes for women with advanced and relapsed endometrial cancer by exploiting replication stress in endometrial cancer.